2024 Epithelial Stem Cells and Niches Gordon Research Conference and Seminar

Abstract
Adult epithelia regenerate during adult life due to the constant activity of stem cell pools. Stem cells maintain
tissue homeostasis and repair injury by close communication with their tissue environment, known as "niche.”
Niches are complex, structured arrays of different cell types that guide tissue stem cell dynamics. The ultimate
goal of understanding epithelial stem cell regulation is to repair or replace cells or organs damaged by injury,
disease, and aging. The strategies vary from generating cell types and tissues in a dish for transplantation
purposes to directly stimulating the damaged organ in the living organism. This field has been exponentially
growing for the past decade. Tissues such as human skin and cornea have already been grown in 3D cultures
and used in clinics to fight otherwise incurable medical conditions. The GRC on Epithelial Stem Cells and Niches
will focus on comparative principles of adult epithelial stem cell dynamics and niche signaling in the homeostasis
of different tissues. This conference will include work on the molecular control of stem cell function from the
epidermis and its appendages, intestine, lung, mammary gland, cornea, prostate, and emerging work from other
epithelial tissues. All model organisms are welcome. This GRC has held meetings in 2016, 2018, and 2022.
We will continue to bring in both new and veteran speakers to allow a variety of participants to contribute to this
exciting meeting over the coming years. In particular, for the 2024 meeting, we have built a scientific program
that emphasizes key cutting-edge areas in epithelial biology, including organoid techniques, imaging and single-
cell analysis, bioengineering, metabolism, modeling disease, and mechanobiology. In addition, we will support
the attendance of graduate students, postdocs, and early career scientists as they make their way into this
exciting field of study by hosting a GRS in the two days prior to this GRC.
A critical feature of the GRC’s scientific mission is to engage the next generation of scientists. We are continuing
our two-day Gordon Research Seminar (GRS) for graduate students and postdoctoral fellows that will precede
this GRC. The GRS will allow students and fellows to share and discuss unpublished data and technical
breakthroughs, favoring collaborative efforts and sparking provocative hypotheses to be discussed on the floor
of the main conference. Furthermore, the participants will have the opportunity to establish tight professional
relationships from which they will benefit throughout their careers. GRS participants will be expected to stay for
the GRC, further contributing to the educational value of this conference.

Public health relevance
Project Narrative Understanding epithelial stem cell regulation within tissues will serve to repair or replace cells or organs damaged by injury, disease, and aging. The strategies vary from generating cell types and tissues in a dish for transplantation purposes to directly stimulating the damaged organ in the living organism. This field has been exponentially growing for the past decade, and this conference will allow bringing together scientists from currently disparate areas, which will create synergy and result in faster progress in this field that is highly medically significant.